Planning Grant for Take off Pounds Sensibly (TOPS) for Breast Cancer Survivors

Our long-term goal is to decrease the weight-related breast cancer and cardiovascular disease mortality among breast cancer survivors. In the R01 application, our overall objective is to determine the real-world effectiveness of the materials developed during the R34 – Take off Pounds Sensibly (TOPS) for Breast Cancer Survivors – on weight. Our central hypothesis is that TOPS for Breast Cancer Survivors will help participants achieve significant weight loss. This hypothesis is based on the following: 1) our preliminary data show that TOPS can help women achieve and maintain significant weight loss; 2) the materials from the Moving Forward and Lifestyle, Exercise and Nutrition (LEAN) studies, which we are adapting to add to the TOPS program to create TOPS for Breast Cancer Survivors, have been shown to help breast cancer survivors achieve significant weight loss; and 3) the additional materials will be approved by breast cancer survivors who have already participated in the TOPS program. To plan to test the central hypothesis, we will pursue the following specific aims in the R34: 1) Adapt materials from Moving Forward and LEAN with the input of breast cancer survivors; 2) Conduct a pilot test of the new materials and study processes where we a) recruit participants through the electronic health record; b) convert from a peer-led to a dietitian-led intervention for the initiation phase; c) transition participants to TOPS chapters in the community for the maintenance phase; and d) collect data in a virtual setting and in the community. The proposed research is innovative because for the following reasons: 1) it combines efficacious weight management programs developed at academic institutions with a low-cost community-based program with national infrastructure; 2) it transitions participants to a maintenance phase in their communities where they can receive ongoing support indefinitely; 3) it collects data via Bluetooth scales and at LabCorp and Quest Diagnostics sites in their communities; and 4) to our knowledge, this is the first study to test a sustainable weight management intervention for breast cancer survivors. The proposed research is significant because it will develop the evidence base for a scalable weight loss intervention among breast cancer survivors. The rationale for this project is that the successful completion is expected to provide evidence that a community-based, weight loss program with a national infrastructure can help breast cancer survivors manage their weight, which may decrease their breast cancer recurrence and mortality; reduce CVD morbidity and mortality; and improve their quality of life.

Public health relevance
The proposed research is relevant to public health because if a low-cost, community-based weight loss program with a national infrastructure is effective at weight loss among breast cancer survivors with excess weight, it has the potential to reduce breast cancer recurrence and mortality and cardiovascular disease mortality among breast cancer survivors. The proposed research is relevant to the part of the NIH mission that pertains to enhancing health and reducing illness and disability.